CHIME Research Education Component (REC)

Project Summary for the RCMAR CHIME Research Education Component
Building on a highly successful 20-year track record of developing scientists who conduct minority aging
research, the Research Education Component (REC) aims to develop faculty by supporting our theme of
“Developing, Adapting, and Evaluating Interventions to Improve the Health of Racial/Ethnic Minority Elders”,
which incorporates two RFA research objectives: i) identify and develop solutions to eliminate health disparities
and health inequities in the growing population of older adults, and ii) improve the health and well-being of
older adults. The REC Specific Aims are to: 1) Identify, recruit, and encourage URM faculty with demonstrated
research potential and interest in minority aging research to apply as RCMAR scientists, 2) Select, with input
from External Advisors, at least 3 outstanding scientists to receive 1-year pilot studies (up to $55,000 each
inclusive of UCLA CTSI funds), 3) Provide intensive individual mentorship, an educational plan and a broad
array of resources to enable scientists to complete, present, and publish their research and ultimately obtain
independent funding, and 4) Monitor the progress of the scientists using a program of progress reports,
mentorship committee meetings, and brief monthly progress review by the CHIME Executive Committee (EC).
For this application, the REC has identified 3 RCMAR scientists to lead pilot projects: 1) Utibe Essien, MD,
MPH, Assistant Professor of General Internal Medicine and Health Services Research, at UCLA (as of Jan
2023) will work with mentor Dr. Mangione to examine i) whether race and ethnicity are associated with frailty in
Veterans with incident Atrial Fibrillation (AF); ii) whether the presence frailty influences known racial and ethnic
inequities in the use of anticoagulation for Veterans with incident AF; iii) whether frailty is a determinant of
switching from warfarin to direct oral anticoagulant therapy for anticoagulation. 2) Chioun Lee, PhD, Assistant
Professor of Medical Sociology at UC Riverside, will work with Drs. Link and Brown, to examine the
progression of multimorbidity after age 50 and to quantify the mechanisms through which health disparities at
the intersection of race/ethnicity and sex are created, using data from the Health and Retirement Study
(HRS,1992–2020). 3) David Lee, MBA, MD, Clinical Instructor, Division of Geriatrics at UCLA, will work with
Drs. Lo and Hays using Kaiser Permanente Northern California data to study the association of dementia and
hip fracture and to understand differences by race and ethnicity, particularly among Asian American and
Pacific Islander subgroups. The 3 proposed pilots address socioeconomic, health care, cultural, social, and
psychological factors and physiological indicators across four levels of analysis (environmental, sociocultural,
behavioral, and biological) of the NIA Health Disparities Research Framework (See Figure 1 in Overall), along
with classifying race/ethnicity as a critical factor in addressing health disparities. All three pilot studies will
provide findings that inform the design of future interventions to improve the health of older adults. In 2018-23,
CHIME has trained 18 scientists who have 154 publications and obtained over $17M in funding.